Career Enhancement Program

ABSTRACT – CAREER ENHANCEMENT PROGRAM
The Cancer Health Disparities SPORE in Endometrial Cancer Career Enhancement Program (CEP) supports
research activities for oncology clinicians, oncology clinician scientists, and basic, translational, and clinical
scientists with strong interest in cancer health disparities and endometrial cancer research. The SPORE
leadership is committed to increasing the pool of endometrial cancer researchers. Each year the CEP will fund
2 CEP investigators from a total of $100,000 in SPORE and matched Institutional funds. We will recruit faculty
with an existing endometrial cancer science focus; or have existing health disparities research expertise that is
newly being applied to the endometrial cancer context to expand the field. The Cancer Health Disparities SPORE
in Endometrial Cancer CEP will provide a rigorous mentorship program for all awardees and a broad ongoing
evaluation of their progress. The SPORE and CEP additionally provide fiscal administration, biostatistics and
bioinformatics input, biospecimens, genomics and pathology expertise; patient perspective and integration with
community outreach activities; mentorship and critical analysis and constructive feedback on progress via CEP
advisory board meetings.